Stakeholder Engagement Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Stakeholder Engagement Core (Core C)
The stakeholder engagement core has two primary functions. The first is to inject in the research projects deeper
practical experience in the prevention, treatment, and care of people living with ADRD and their families and
caregivers. The second is to magnify the translational impact of the findings in stakeholder communities. A critical
early task of the stakeholder engagement core is to compile a list of stakeholder organizations that span the
breadth of societal interactions and care for people living with ADRD. The list will include advocacy groups, state
and federal government agencies, provider groups, and representatives from numerous industries:
pharmaceuticals, biotechnology, private equity/venture capital, foundations and venture philanthropy, insurance,
healthcare, long-term care, accountable care, and geriatrics, to name a few. A related early task is to lay out a
stakeholder engagement plan that delineates a process for reaching out to stakeholders, gathering input on
research priorities, the appointment of a stakeholder advisory group, the creation of a dedicated area of the
consortium website for stakeholder communication and resource sharing, and a monitoring and oversight plan
for assessing stakeholder engagement activities and accomplishments. We will convene formal stakeholder
meetings twice annually. We anticipate organizing these meetings with targeted groups that best represent on
the ground experience in one of the thematic priorities at a time – rather than complicating these meetings with
multiple categories of stakeholder groups. One meeting might focus on understanding new drug development,
another on formal and informal caregiving, another on health disparities, for example. Early meetings would be
largely to learn from stakeholders, and to improve the research plans, based on the on the ground experience
of the stakeholders. Later meetings would focus more on the translational opportunities inherent in the research
findings.